Therapeutic Targeting of Macrophage PI3Kgamma in HNSCC

ABSTRACT

There is a critical need to develop novel therapies for head and neck squamous cell carcinoma (HNSCC). The
incidence of HPV-­related HNSCC is rapidly rising in the United States and other countries around the world,
while tobacco-­related HNSCC remains an aggressive disease with poor prognosis and limited therapeutic
options. Worldwide, HNSCC accounts for over 600,000 cases annually and is a leading cause of cancer
mortality in developing countries. A majority of HNSCC patients present initially with locally or locoregionally
advanced disease, yet these patients largely succumb to locally recurrent disease. Gene expression profiling
and modeling strongly support a critical role for inflammation in HNSCC initiation and progression. Immune
therapy holds promise for the treatment of HNSCC, as the immunotherapeutic agent nivolumab (anti-­PD-­1)
recently demonstrated clinical activity in a small percentage of patients with recurrent/metastatic HNSCC.
However, these findings suggest that HNSCC patients would be excellent candidates for novel immune
therapeutics that could target resistance to anti-­PD-­1. We have found that PI3Kγ in immune suppressive
Tumor Associated Macrophages (TAMs) promotes tumor immune suppression and resistance to checkpoint
inhibitors in mouse models of HNSCC. Genetic or pharmacological inactivation of PI3Kγ, but not of other PI3K
isoforms, repolarized TAMs toward a pro-­inflammatory, anti-­tumor phenotype and synergized with checkpoint
inhibitors to activate memory T cells and eradicate HNSCC tumors. Our studies indicate that PI3Kγ inhibitors,
such as the investigational agent IPI-­549, may be valuable immune oncologic agents to treat and monitor
HNSCC patient outcomes. Our studies also identified a novel PI3Kγ-­driven signature of immune suppression -­
that predicts decreased survival in HNSCC patients. We propose to test the hypothesis that this PI3Kγ-­
mediated signature of immune suppression can be used to monitor therapeutic responses to PI3Kγ inhibitors.
We will also test the hypothesis that therapeutic strategies that block PI3Kγ-­mediated immune suppression will
synergize with T cell targeted therapeutics to improve outcomes in HNSCC patients. The specific aims of this
proposal are 1) To Identify the mechanisms by which PI3Kγ inhibitors synergize with anti-­PD-­1 to promote T
cell recruitment and activation in vivo, using mouse models of HPV+ and HPV-­ carcinogen-­induced HNSCC, 2)
To determine the effect of the PI3Kγ inhibitor IPI-­549 on tumor immune responses in patients with resectable
HNSCC, 3) To evaluate biomarkers of immune response in recurrent/metastatic HNSCC patients treated with
IPI-­549 in combination with anti-­PD-­1.

Public health relevance
NARRATIVE The incidence of HPV- related head and neck squamous cell carcinoma (HNSCC) is rapidly rising in the United States and other countries around the world, while tobacco- related HNSCC still remains an aggressive disease with poor prognosis and limited therapeutic options. There is a thus critical need to develop novel therapies for HNSCC. The goal of this proposal is to test novel immuno- oncologic therapeutic approaches for HNSCC and identify novel immune biomarkers that can assess the mechanism of action of these novel therapeutics.